STRUCTURAL STUDIES OF THE RNA COMPONENT OF RNASE P

DESCRIPTION (Adapted from abstract): This is a revised proposal. RNA is central to a multitude of important cellular processes and is also unique among nucleic acids in being able to catalyze chemical reactions. Despite its importance, very little is known about the atomic structure of RNA molecules larger than 50 nucleotides. The applicants are interested in the structure of large RNA molecules and hence have focused attention on the RNA component of ribonuclease P (Rnase P). RNase P is the endonuclease responsible for cleavage of the 5' end of pre-tRNA leading to tRNA maturation. Both the Rnase P RNA (P RNA) from Bacillus subtilis and Escherichia coli are formed by two independent domains. Domain I is approximately 150 nucleotides long (about 52 kDa) and is involved in tRNA recognition. The applicants have crystallized domain I from both B. subtilis and E. coli and have started to elucidate their atomic structures. The long term goal of this project is to understand the structure and function of RNase P RNA. The specific aims of this proposal are: To elucidate the atomic structure of domain I of B. subtilis P RNA. Crystals are already in hand, and they diffract to at least 4.0 A. To improve the crystals of domain I of B. subtilis P RNA to be able to obtain atomic resolution information. To elucidate the structure of domain I of E. coli P RNA (M1 RNA). Preliminary crystals have already been obtained. To compare the structure of domain I from B. subtilis and E. coli to identify the features important for their similarities and differences. The work on P RNA is relevant to other studies of large RNA molecules and, in particular, to the study of catalytic RNA molecules.